The spinal cell atlas of opioid-targeted inflammasomes in the HIV pain model: mechanism and pathogenic role

SUMMARY
Opioid analgesics are still commonly prescribed to alleviate severe pain in patients with HIV-1/AIDS. However,
chronic opioid treatment paradoxically leads to opioid-induced hyperalgesia (OIH), a heightened pain state that
requires escalating dosages for opioids to be effective. This side effect directly contributes to opioid overdose
and epidemics. Despite the common use of opioids, the mechanism underlying OIH in the context of HIV-induced
pain remains unknown, which hinders the development of effective interventions. Recently, we found that
morphine exacerbates pain in the HIV-1 gp120 pain model and causes neuroinflammation in the spinal dorsal
horn (SDH), the pain processing center in the spinal cord. Emerging evidence indicates that inflammasomes
play a critical role in controlling neuroinflammation during pain pathogenesis, including OIH. Our studies suggest
that morphine induces neuroinflammatory phenotypes in the SDH, including glial activation (e.g., astrocytes),
cytokine expression (e.g., IL-1β), and inflammasome activation, and that the neuroinflammatory phenotypes are
exacerbated in the gp120 pain models. We further demonstrate that Wnt5a signaling from neurons is essential
for morphine to activate neuroinflammation and inflammasomes during OIH pathogenesis. Collectively, our
preliminary data suggest that morphine targets inflammasomes in the SDH via neuronal Wnt5a signaling to
regulate neuroinflammation during OIH development, and that HIV-1 gp120 enhances these effects of morphine.
Hence, we hypothesize that morphine induces distinct cell distribution patterns of inflammasomes in the pain
neural circuits, that Wnt5a signaling plays a critical role in setting up the cell maps of inflammasomes induced
by morphine, and that inflammasomes compartmentalized in different cells cooperatively promote OIH
pathogenesis. We also hypothesize that HIV-1 gp120 enhances these effects of morphine. To test the
hypotheses, we will construct cell atlas of the opioid-targeted inflammasome in the spinal cord of HIV pain models
(Aim 1), elucidate the role of Wnt5a signaling in the establishment of inflammasome cell maps (Aim 2), and
determine the contribution of glial type-specific NLRP3 to OIH pathogenesis in the context of HIV-Associated
pain. Results from this study will reveal the molecular mechanism and the pathogenic role of opioid-targeted
inflammasomes in the CNS in the context of HIV-associated pain.

Public health relevance
NARRATIVE Opioid analgesics are commonly used by HIV/AIDS patients for pain control, but their chronic use may lead to paradoxical pain. This project will help us improve the understanding of the underlying pathogenic mechanism and facilitate the development of effective intervention.